BIOAVAILABILITY IN FASTING OF SANDIMMUNE ORAL SOLUTION VERSUS SOFT GEL CAP

Evaluate the bioavailability of Sandimmune oral solution and Sandimmune soft gelatin capsules in renal transplant patients who absorb cyclosporine poorly. We are in the beginning stages of this protocol thus recruitment and enrollment are our main focus.